PHVA CONCENTRATION IN SCHIZOPHRENIC PATIENTS DURING CHANGE OF STATE

This study will examine if, in remitted schizophrenic patients, plasma homovanillic acid concentrations (pHVA), the main metabolite of dopamine in man, change when those patients exacerbate.